Program in Translational and Experimental Hematology

Benign and malignant blood diseases cause major morbidity and mortality in the US and
are rising in prevalence due to the rapid aging of the American population. Effective
therapies are rare in part because of an insufficient number of physician-scientists and
PhD scientists trained in Hematology research. Our Training Program in Translational
and Experimental Hematology addresses this important problem by supporting the
training of investigators in basic science or translational research in Hematology. We
have designed a Training Program with rigorous research opportunities and close
mentoring by faculty. Our Program provides an outstanding panel of leading experts in
Hematology as Program Faculty to direct fellows in their research endeavors. Physician-
scientists enter the T32 Training Program after clinical training in adult Hematology. PhD
fellows enter the Program directly from the laboratories of Program Faculty through a
competitive process. Physician-scientists interested in translational research and clinical
investigation have the option of pursuing a Master’s Degree in Clinical Epidemiology to
acquire skills in the design of clinical trials. Fellows in the T32 Program receive training
in three broad areas of hematology research: hematopoiesis and stem cell biology;
thrombosis and vascular biology; and immunology and immunotherapy. Research in the
Training Program comprises two years and is enhanced by didactic lectures, outstanding
seminar series and a rich scientific environment. This Training Program in Translational
and Experimental Hematology contributes new biological insights, novel means of
prevention and new therapies for blood disorders through postdoctoral training of fellows
in Hematology research and by preparing future investigators for careers in research in
Hematology.

Public health relevance
Narrative This Training Program trains future physician-scientists and PhD scientists with the rigorous research skills necessary to solve fundamental problems in Hematology. The Program will include training in both a Basic Science Research Pathway and a Translational Research Pathway. Training will focus on three high priority areas in Hematology research, including: hematopoiesis and stem cell biology; thrombosis and vascular biology; and immunology and immunotherapy. The Training Program will prepare the fellows for successful, independent careers in research in Hematology and for new discoveries in understanding and treating blood diseases.